Fetal Origins of Testicular Cancer: A Metabolomics Study in Newborns

PROJECT SUMMARY/ABSTRACT
Testicular cancer, mainly comprised of testicular germ cell tumors (TGCT), is the most common solid tumor
among adolescent and young adult males. Its incidence has increased dramatically during the past 40 years
worldwide and in the US. Compared to other racial/ethnic groups, Latinos experience the highest increase in
both incidence and mortality rates since 2000, leading to major health disparities. In addition, the disease burden
is high in terms of serious life-long treatment-related complications in cancer survivors, and years of potential
life lost in this young population. As a result, etiologic and prevention research of TGCT is of high public health
importance. The rapid increase in TGCT incidence suggests that environment plays an important etiology role,
yet no environmental risk factors to date have been identified. Some reports have suggested that exposure to
endocrine disrupting chemicals during pregnancy may be associated with future risk of TGCT, but no human
studies have directly tested this hypothesis. TGCT is believed to have fetal origin and to develop from an initiating
event occurring in utero, resulting in a precursor lesion that progresses to TGCT in nearly all cases; the difficulty
in obtaining prospectively collected (pre-diagnosis) biological specimens from this critical period of development
(prenatal) has posed a major limitation to the identification of environmental risk factors. The field of “exposomics”
studies all relevant chemical exposures; metabolomics platforms estimate the “internal” environment of an
individual that may identify both exogenous exposures involved in disease development. By leveraging newborn
dried blood spots archived by the state of California on all infants born in the state, we will conduct a detailed
“exposomic” analysis of fetal life that could identify environmental triggers in TGCT etiology. Using an untargeted
analysis which measures thousands of exogenous and endogenous metabolites simultaneously permits us to
make inference on fetal exposure and in utero metabolism and biologic response. Additionally, we will apply
novel statistical methods that simultaneously examine thousands of biochemical signatures. Using a semi-
targeted approach, we will also test the hypothesis that birth levels of phthalates, an endocrine disruptor
associated with male genital anomalies, is associated with TGCT risk. Our proposed study is novel in that it
overcomes conceptual and methodological challenges that have hindered previous studies of the fetal origin of
TGCT (especially access to blood specimens collected at birth to characterize the fetal/neonatal periods); utilizes
untargeted and semi-targeted approaches to identify a large number relevant biochemical signatures and to test
current hypotheses in TGCT environmental epidemiology; and uses novel statistical methods to examine two
and three way interactions without the need for large sample sizes. Our large and ethnically diverse California-
based study population will provide the opportunity to fill important knowledge gaps about the factors contributing
to TGCT.

Public health relevance
PROJECT NARRATIVE Testicular cancer is the most common cancer among male adolescents and young adults, and its incidence has increased dramatically during the past 40 years in the US and worldwide, suggestive of environmental influences. However, the identification of environmental risk factors has been problematic, largely due to 1) difficulties in obtaining pre-diagnostic biological specimens from the prenatal period (testicular germ cell tumors are believed to originate in utero) and 2) methodological and statistical issues arising the measurement of large numbers of exogenous and endogenous exposures. The overall goal of this application is address these two issues by barriers by leveraging metabolomics platforms to study the “exposome” of the subjects, by measuring thousands of exogenous and endogenous metabolites in the same assay, from neonatal newborn blood specimens.